Flow Cytometry and Cell Analysis Core

Abstract
The Flow Cytometry and Cell Analysis (FCCA) Core at the COBRE Center for Dietary Supplements and
Inflammation (CDSI) is a continuation of Phase-1 and Phase-2 research support facilities specifically in the areas
of Flow cytometry and cell sorting, Single-Cell RNA sequencing (scRNA-seq), and Single-Cell Spatial
Transcriptomics, and some in vivo studies such as endoscopy and colonoscopy. This Core has been highly
innovative and extensively used in the past including 18 Research Project Leaders (RPLs) and 26 Pilot Project
Leaders (PPLs) as well as numerous other investigators. One of the focuses of this Core is to provide multi-
parameter flow cytometry and sorting services for phenotyping and isolation of specific cell types, determination
of cell proliferation, differentiation, apoptosis as well as expression of signaling molecules, transcription factors,
and cytokines at the protein level in inflammation and following treatment with botanicals. Flow cytometry is a
much-needed technology for all immunological studies to rapidly analyze single cells. In addition to the analysis
of cells, a major application of flow cytometry is sorting cells for further functional analysis or for adoptive transfer
to corroborate their properties and functions. The flow cytometry in this Core has been updated with recent
technologies and equipment such as BD FACS-Aria II, which is a high-performance cell sorter and flow
cytometer capable of sorting up to 70,000 events per second. In addition, this core has a Beckman Coulter
FC500 Flow Cytometer which complements the capabilities of the FACS ARIA II. We have also recently
procured, a BD Celesta Flow Cytometer that can run up to 14 colors, BD-Symphony Flow Cytometer (50
parameters capable), as well as a BD FACSymphony S6 sorter which has 5 lasers, 23 color detectors, and 6-
way sorting capability. This Core will also provide Single-Cell RNA sequencing (scRNA-seq), a technology that
allows transcriptomic analyses of individual cells. Additionally, the Core will also offer the latest technology,
Single-Cell Spatial Transcriptomics, which allows to capture the transcriptional activity within an intact tissue,
either for regions or single cells. By analyzing single cells within a complex population mix, these technologies
allow the delineation of how inflammation before or after treatment with botanicals may affect individual and rare
cell types within that organ or tissue. Additionally, this Core will support in vivo studies such as mouse endoscopy
to study inflammation in the colon during colitis and colon cancer, as well as plethysmography to study the
functions of the lungs during acute lung inflammation. The Core will continue to provide training to the faculty
and lab personnel for performing cutting-edge research, including experimental design, operation of equipment,
and training on instrumentation. In addition to individual interactions, didactic courses, seminars, and workshops
will be regularly sponsored. The Core has developed several innovative approaches to increase the critical mass
of users thereby providing sustainability to the Core facility.